A Novel Hsp90 Inhibitor as a Chemo and Radiosensitizer in Adults with Glioblastoma

PROJECT SUMMARY
Glioblastoma is a lethal primary brain tumor with limited treatment options. The current standard therapy with
combined chemoradiation therapy (chemoRT) with temozolomide (TMZ), an alkylating agent offers a median
survival of only 16-18 months. There is an urgent need for novel therapies especially those that can overcome
resistance to chemoRT. Cancer cells develop complex resistance mechanisms that enable them to survive the
effects of conventional therapies. One such evolutionally conserved mechanism is the heat shock response
(HSR) which can deploy several diverse defense processes in the setting of adverse environmental conditions.
The HSR is mediated by heat shock proteins (HSP), a class of molecular chaperones that shuttle and
configure client oncoproteins into proper functional states. In preliminary studies, we show that onalespib, a
novel long acting inhibitor of heat shock protein 90 (Hsp90), a critical mediator of the HSR in cancer cells,
blocked tumor growth, invasion and angiogenesis in gliomas suggesting the potential for a strong independent
antitumor effect. Relevant to this proposal, onalespib sensitizes glioma cells to TMZ and RT in patient-derived
(PDX) cell lines and in a zebrafish and mouse intracranial glioma animal models. Based on these data, in this
grant submission, we propose a phase I clinical trial through the NCI-funded Adult Brain Tumor Consortium to
identify the maximum tolerated dose of the combination of onalespib with chemoRT in adults with newly
diagnosed GBM. We also propose to conduct key correlative tissue and plasma studies through the following
specific aims: Aim 1 will identify the MTD of onalespib in combination of chemoRT and adjuvant temozolomide
and will determine whether onalespib can cross the blood brain barrier and achieve sufficient concentrations in
enhancing and non-enhancing glioma tissue compared with plasma levels. Aim 2 will determine the
pharmacodynamic effects of onalespib by assessing whether onalespib can inhibit Hsp90, its target, in human
GBM tissue obtained in this trial and whether this inhibition can affect its chaperone oncoprotein clients
particularly those relevant to DNA repair and cell survival against the effects of RT and TMZ. In Aim 3, we will
conduct co-clinical trials using PDX intracranial glioma models and organotypic human glioma slices to
determine the mechanisms of sensitivity and resistance to onalespib effects to provide insights that can help
modify the subsequent phase II trial. This is the first human trial of an Hsp90 inhibitor in brain tumors and the
first to combine an Hsp90 inhibitor with chemo- and radiation therapy against GBM. Successful completion of
this trial will enable us to proceed to a Phase II efficacy trial (approved by NRG oncology) and will provide
comprehensive PK and PD data that can help the development of onalespib and Hsp90 inhibitors in other
malignancies.

Public health relevance
PROJECT NARRATIVE Glioblastoma, a lethal primary brain tumor, has limited treatment options; the current standard therapy with combined chemotherapy (with a drug called temozolomide) and radiation therapy results in a median survival of only 16-18 months highlighting the urgent need for novel therapies. In a search for drugs that can overcome resistance to chemotherapy and radiation therapy, we have identified that blocking the activity of heat shock protein 90 (Hsp90), a protein complex that is critical for tumor cell survival and treatment resistance, using a novel drug called Onalespib which we have shown can cross the blood brain barrier, can make glioma cells more sensitive to temozolomide and radiation therapy, slow down glioma growth in animals and extend their survival. Building on these promising results, we will conduct a trial that will assess the clinical benefit of blocking Hsp90 using onalespib along with chemoradiation in brain tumors and which bears promise of providing a new treatment option for patients with glioblastoma as well as providing valuable new information related to whether onalespib can block its targets in tumor tissue that can benefit studies in other cancers which are exploring the effects of Onalespib.